Enzymology of Mismatch Repair in Yeast

PROJECT SUMMARY
DNA mismatch repair (MMR) plays critical roles in eukaryotic cells including: 1) suppressing mutations that
result from misincorportation errors during DNA replication that escape DNA polymerase proofreading; 2)
suppressing mutations that result from misincorporation events that occur due to chemical modification of DNA
or DNA precursors; 3) preventing genome rearrangements due to recombination between divergent DNA
sequences; 4) correcting mispaired bases in recombination intermediates; and 5) detecting DNA damage and
activating signaling pathways linked to cellular responses, including cell cycle control and cell death.
Consequently, MMR defects cause increased rates of accumulating mutations and genome rearrangements
resulting in a characteristic genome instability signature and resistance to killing by some DNA damaging
agents. In humans, MMR defects underlie both inherited and sporadic cancers, cause tumors to become
resistant to some chemotherapy agents and appear to cause quite striking sensitivity of cancers to
immunotherapy. Thus, a better understanding of MMR pathways and the consequences of MMR defects will
impact human health by: 1) informing our understanding of MMR status; and 2) guiding improvements in the
development and use of therapies for MMR-deficient cancers.
The proposed studies use Saccharomyces cerevisiae as a model system to study the mechanisms of the
conserved eukaryotic MMR pathways. The following lines of investigation will be carried out: 1) genetic
approaches will be used to study Msh2- and Mlh1-interacting proteins, identify new MMR proteins and study
the activation of the Mlh1-Pms1 endonuclease; 2) reconstitution approaches will be used to study the MMR
pathways in which mispair excision is mediated by either Exo1 or the Rad27 endonuclease focusing on mispair
excision mechanisms, the recruitment of Exo1 and Rad27 to MMR reactions and whether DNA pol ε can act in
Rad27-mediated MMR; 3) reconstitution approaches will be used to study MMR pathways that are dependent
on the Mlh1-Pms1 endonuclease including pathways where Mlh1-Pms1 initiates mispair excision by Exo1 and
Rad27 and a novel, newly reconstituted pathway where mispair excision is mediated only by Mlh1-Pms1;
and, 4) individual steps in MMR reactions will be studied primarily by investigating the protein-protein
interactions and higher order complexes of proteins that drive MMR using Surface Plasmon Resonance and
single molecule biochemistry methods. The long-term goal of these studies is to develop a detailed
understanding of the biochemical and molecular mechanisms of MMR and how cells utilize MMR to prevent
mutations and genome rearrangements. Because MMR is highly conserved, the results from studies of S.
cerevisiae MMR will provide insights into the mechanisms of MMR in human cells. Consequently, this project
will provide insights that can be applied to understanding the genetics of human cancers and the biology of
MMR defects in human cancers in addition to providing a basic understanding of MMR mechanisms.

Public health relevance
PROJECT NARRATIVE Mismatch repair (MMR) defects cause inherited cancer susceptibility in humans, play a role in the development of a proportion of many types of sporadic human cancer and are predictive of a striking response to cancer immunotherapy using checkpoint inhibitors. This project will provide new insights into both the mechanisms of MMR and the function of the proteins that catalyze MMR. The results of this project will provide a better understanding of basic MMR mechanisms and will potentially impact the development of clinical tests for the MMR status of patients and tumors and improvements in cancer therapy.